Serological Biomarkers for Monitoring Human-Vector Contact by Invasive Anopheles stephensi in Africa

Project Summary
Serological Biomarkers for Monitoring Human-Vector Contact
by Invasive Anopheles stephensi in Africa
Anopheles stephensi was historically considered a major malaria vector in urban environments in
Southeast Asia, the Middle East and the Arabian Peninsula. Since its first detection in Djibouti in
2012, the distribution of this vector species has expanded to Ethiopia, Sudan and Somalia in the
Horn of Africa, and Nigeria in west Africa. Establishment and spread of An. stephensi in Africa
pose major challenges for malaria control and elimination in fast-growing urban Africa because
An. stephensi is a confirmed vector for local African Plasmodium falciparum and P. vivax strains
and is resistant to multiple classes of synthetic insecticides. Accordingly, the World Health
Organization recently established an initiative to take concerted actions to stop the spread of An.
stephensi by improving surveillance and control of this species in Africa. However, the commonly-
used mosquito surveillance methods such as CDC light traps, human landing catches and larval
dipping methods lack the necessary sensitivity in urban settings due to environmental light
pollution and low vector abundance. However, sensitive surveillance of An. stephensi is critical to
its early detection and control. Recently, serological methods for monitoring human-vector contact
by measuring antibody response to mosquito salivary proteins have been developed. However,
the available serological method is based on well-conserved proteins and cannot be used to
differentiate An. stephensi exposure from those of native Anopheles species. The objective of this
R21 application is to develop serological biomarkers that can distinguish exposure to invasive An.
stephensi from the native African malaria vector species using novel peptide microarray
technology. Two aims are proposed: 1) identify salivary peptides that distinguish the exposure of
invasive An. stephensi from the native African malaria vector species, An. arabiensis, using novel
peptide microarray technology; and 2) evaluate candidate salivary peptides using human plasma
from field sites with contrasting An. stephensi distribution in Ethiopia. The new tool from this
project can be used to measure human-vector contact with the invasive An. stephensi, and thus
help assess the role of An. stephensi in malaria transmission. Serological biomarkers have the
potential to be utilized in domesticated animals, the main blood source for An. stephensi
mosquitoes. This could enhance the detection sensitivity of invasive An. stephensi mosquitoes,
thereby facilitating the surveillance and control of An. stephensi populations in Africa.

Public health relevance
Project Narrative Population establishment and spread of Anopheles stephensi mosquito in Africa pose major challenges for malaria control and elimination in Africa. Sensitive surveillance of An. stephensi is critical to its early detection and control. The new serological surveillance tools to be developed by this project will distinguish the exposure of invasive An. stephensi from the native African malaria vector species, and thus greatly support the surveillance and control of An. stephensi in Africa.